Mechanism of nerve growth factor driven axon plasticity

PROJECT SUMMARY/ABSTRACT
Axon plasticity, in the form of the generation of axon branches, is fundamental to the
development and repair of neuronal circuitry. In this project we will address the main hypothesis that
the intra-axonal glycolytic pathway is required for the formation and maintenance of axon branches in
vitro and in vitro. Live imaging approaches, molecular manipulations, pharmacology and optogenetic
ablation of glycolytic enzymes will be used to determine the role of the glycolytic pathway. The project
will also address the link between the glycolytic pathway and the cytoskeletal remodeling underlying
axon branching.

Public health relevance
NARRATIVE The development of neuronal morphology is a complex process dependent on cellular energy sources. This project aims to determine the role of intra-axonal glycolysis in nerve growth factor regulated axon extension, growth cone dynamics and axon branching.